Identifying genetic vulnerabilities in KIAA1549-BRAF mutant pediatric low-grade gliomas

Project Summary:
Pediatric low-grade gliomas (pLGGs) typically harbor only a single oncogenic driver event which almost
universally result in MAPK pathway activation. The most frequent of these alterations is a rearrangement that
fuses the C-terminus of BRAF to the large transmembrane protein KIAA1549. Many patients whose tumors
harbor this fusion respond to BRAF inhibitors, but challenges remain in extending clinical benefit to all patients.
A key challenge is that patients require chronic treatment with these inhibitors throughout childhood because
tumors often rebound upon cessation of treatment. These inhibitors are associated with significant dose-limiting
toxicity issues, likely because the MAPK pathway is essential for brain development. These observations suggest
that we need to identify new therapeutic targets for pLGG.
The two core members of the POMT complex and two complex cofactors emerged as the top four dependencies
in a genome-scale loss of function CRISPR/Cas9 screen. This dependency was specific for cells harboring the
KIAA1549-BRAF fusion and were not dependencies in cells expressing BRAFV600E. The POMT complex is
necessary for O-mannosylation of secreted and transmembrane proteins. This is striking because across all
proteins in the human proteome, KIAA1549 one of the proteins most affected by this post-translational
modification. It was originally hypothesized that the KIAA1549-BRAF fusion activates BRAF by truncating its
negative regulatory domain, but this observation suggests that the KIAA1549 portion of the fusion may also be
necessary for activating BRAF.
The primary goals of this proposal are to understand why the POMT complex is a vulnerability in KIAA1549-
BRAF mutant cells, and to understand how the KIAA1549 portion of KIAA1549-BRAF regulates the activity of
the fusion. In Aim 1 I will test the hypothesis that POMT complex activity is necessary for the survival of
KIAA1549-BRAF-dependent cells. In Aim 2 I will test the hypothesis that the POMT complex is required for O-
mannosylation of KIAA1549-BRAF, and that O-mannosylation of KIAA1549-BRAF is necessary for oncogenic
signaling. In Aim 3 I will test the hypothesis that the KIAA1549 portion of the KIAA1549-BRAF fusion tethers
BRAF to the plasma membrane and enhances its ability to activate the MAPK pathway.

Public health relevance
Project Narrative The most frequent genomic alteration in pediatric low-grade gliomas is a rearrangement that creates a fusion between the oncogene BRAF and the uncharacterized protein KIAA1549. Inhibitors which block the function of this fusion are effective but cause significant toxicity and require continuous dosing throughout childhood. The goal of this project is to define new therapeutic targets in KIAA1549-BRAF mutant pLGGs, with a particular focus on characterizing how the POMT complex regulates KIAA1549-BRAF activity.